Mechanisms regulating inflammatory fibroblasts in wound healing

Project Summary
Wound healing is a central aspect of human health that is a coordinated process involving multiple cell
populations. Interactions between the microenvironment, recruited cell populations, and tissue-resident cell
populations, in particular stromal and immune cell populations, is critical for successful wound healing.
Dysregulated wound healing contributes to fibrosis/fibrotic disorders, which have been attributed to
approximately 45% of deaths in the developed world. Typically in wound healing, inflammation is spatially and
temporally controlled and subsequently the tissue is remodeled by activated fibroblasts and myofibroblasts,
whose presence and survival is also tightly regulated by other cells and environmental cues. In dysfunctional
wound healing, chronic immune cell infiltration and proinflammatory cytokines overlap with the emergence of
fibroblasts poised to promote fibrosis. The fate and function of fibroblasts has been identified to be a
determining factor in wound healing. The inflammatory component of wound healing has been well
characterized and even more so the myofibroblast and ECM components. However, there is a dearth of
studies investigating how immune-stromal crosstalk contributes to wound healing, as well as whether
fibroblasts contribute to perpetuate chronic inflammation. The regulation of inflammation has a critical effect on
downstream fibroblast phenotypes, which also contributes to whether wound healing occurs. Recent work has
characterized a specific fibroblast subpopulation, inflammatory fibroblasts, that contributes to inflammatory
signaling. Yet what is unknown is their role in wound healing and whether the resolution and regulation of
inflammatory fibroblasts is an important aspect of wound healing. Understanding the role and regulation of
inflammatory fibroblasts in wound healing is a central objective of this application. Our lab is focused on
addressing these challenges by integrating single cell approaches, biomaterials, and in vivo models of wound
healing and tissue repair that altogether offer an outstanding opportunity to understand mechanisms regulating
inflammatory fibroblasts and their contribution in either facilitating or hindering wound healing. We propose the
following projects towards addressing these challenges: Project 1) Determinign the contribution of
inflammatory fibroblasts during wound healing; Project 2) Identifying pathways that regulate inflammatory
fibroblasts in wound healing; Project 3) Identifying mechanisms of inflammatory fibroblast-mediated changes to
the ECM. Addressing these challenges will provide fundamental new insights in fibroblast biology,
inflammation, and identifying new avenues for therapeutic approaches.

Public health relevance
Project Narrative The regulation of inflammation has a critical effect on downstream fibroblast phenotypes, which contributes to whether wound healing occurs or fibrosis, which accounts for 45% of deaths within the western world. We identified a population of fibroblasts with an inflammatory signature yet its role in wound healing is unknown. Developing a better understanding of the role, induction, and phenotype of these inflammatory fibroblasts in wound healing will help us identify new mechanisms of disease pathogenesis, new candidates for biomarkers, and new avenues for therapeutic strategies.